Investigations of Spatial Recognition Memory to Improve Cognitive Outcomes in Epilepsy Surgery

Epilepsy is a common neurologic disorder that cannot be controlled with medication in a third of patients. The
most common form of epilepsy, and the most difficult to control, is medial temporal lobe epilepsy. Patients with
epilepsy and their caregivers note substantial cognitive difficulties that are not well correlated with
neuropsychological testing. Emerging evidence suggests this discrepancy is due to the lack of
neuropsychological tests for core deficits in epilepsy. These deficits are primarily related to episodic memory.
Emerging psychological theory places 'scenes' - integrated spatial and object representations - at the core of
episodic memory, recollective experience, and imagining future scenarios. These memory processes appear to
be at the heart of cognitive difficulties in epilepsy and overlap with disturbances in recognition memory that
encompasses both familiarity judgments, including hyperfamiliarity and recollection. Our long-term goal is to
delineate core memory circuits, particularly in relation to the deficits in epilepsy and after epilepsy surgery, and
then develop better means to test these processes and avoid morbidity. To this end, we have updated a unique
paradigm that now includes photorealistic dynamic scenes that can independently assay familiarity and
distinguish this from validated recall. This paradigm addresses core features of memory and memory
disturbances by including objects, spatial features, and temporal dynamics; it can be used to assay familiarity,
recollection, and potentially memory generalization. We hypothesize that coordination between two distinct
memory networks for encoding is required to perform this task during study scenes. During test scenes,
recollective experience is necessary for the task and can overlap with encoding. This coincidence of recollective
experience and encoding is a possible feature of deja vu, which, interestingly, can be elicited by this paradigm.
We will use this approach and other behavioral measures to study a unique and large cohort of patients with
epilepsy surgery-related focal lesions of pertinent brain regions. We will also prospectively test patients before
and after surgery. This is followed by electrophysiological studies with paradigm modifications, including event-
related potentials (in control subjects) and human intracranial electrophysiology (in pre-surgical epilepsy
patients). These approaches will enable us to delineate the precise timing and neural circuits underlying these
phenomena. Our rationale is that through these studies, we can design better tests for memory problems, avoid
surgical injury to memory, and ultimately contribute to developing new memory treatments. We anticipate that
our proposed studies will have impacts that extend beyond epilepsy in the clinical sphere and be highly
informative for psychological theory and computational memory models. These studies will, therefore,
significantly impact our understanding, classification, scoring, and treatment of memory disorders. Innovative
approaches are employed in these studies, and we expect impacts on theory and memory models.

Public health relevance
PROJECT NARRATIVE This work focuses on core and poorly characterized memory defects in patients with temporal lobe lesions and other neurologic diseases such as epilepsy, where there are defects in scene visualization, scene and episodic memory, and recollective experience. This work will provide insights into the nature of memory difficulties and their anatomical and physiological basis, enabling better treatment and avoidance of memory disorders with neurosurgical procedures. This will fulfill the NINDS mission by providing fundamental knowledge of memory systems that can reduce the burden of related neurological diseases.